2023 Excitatory Synapses and Brain Function Gordon Research Conference and Seminar

Project Summary
This proposal requests partial support for a longstanding, well-attended, and well-received Gordon Research
Conference (GRC) on Excitatory Synapses and Brain Function on June 4-9, 2023, at Les Diablerets Conference
Center in Switzerland. The GRC will be preceded by a Gordon Research Seminar (GRS) targeted towards
graduate students and postdoctoral fellows on June 3-4, 2023, at the same location.
Excitatory synapses are functional units that enable rapid signal transmission and communication between
neurons. Through these connections, neurons establish functional circuits that process information necessary to
generate all brain functions. Synapses are the target
aberrant synaptic function is causally linked to several neurological and psychiatric disorders, including
of many commonly prescribed medications, and
schizophrenia, autism, depression, drug addiction, Parkinson's disease, Alzheimer's disease, traumatic brain
Understanding the structure and function of excitatory synapses is therefore
fundamental not only to infer knowledge about brain function but also to find new therapeutic strategies for brain
diseases. The conference will bring together outstanding junior and senior scientists across different disciplines
including neuron biologists, anatomists, molecular and developmental biologists, biochemists, cell/molecular
imagers, biophysicists and neurophysiologists with the goal of
injury, stroke and epilepsy.
stimulating discussions about current concepts
and defining new challenges for future research. The program includes two keynote lectures and eight sessions
that broadly address current issues in synaptic circuit dissection, learning and memory processes, experience-
dependent plasticity, technological advances, synaptic basis of the diseases, NMDA receptor structure and
function, synaptic specification and development, signaling from synapses to genes and back. In addition, poster
sessions will permit all participants to contribute to these topics.
Besides the invited speakers, we will select junior scientists from the submitted abstracts for short oral
presentations. The program has been designed not only to highlight cutting edge approaches and to stimulate
new concepts, methods and technologies within a sound biological framework of fundamental neuroscience, but
also to promote underrepresented groups in science. The conference will bring together expert scientists
worldwide in an environment that is conducive to discussion and exchange of ideas. The exchange of ideas at
this conference has been a driving force for the field. We expect the 2023 GRC on Excitatory Synapses and
Brain Function will shape future scientific directions and provide critical support for the mission of NINDS as well
as other NIH institutes such as NIDA, NIMH, NICHD and NIA.

Public health relevance
Project Narrative Normal brain function relies on the ability of neurons to communicate with each other via synapses. This conference will bring together experts on excitatory synapses and brain function to discuss fundamental molecular and cellular mechanisms of synaptic function, how synapses shape brain activity, and how their aberrant function and contributes to brain disorders.